The second phase of NIH Common Fund 4D Nucleome Network Organizational Hub

The second phase of NIH Common Fund 4D Nucleome Network Organizational Hub
Abstract
The second phase of the 4DN program requires an efficient organizational center to synergize the activities of
all the funded teams and integrate the research products. Accordingly, the 4DN Organizational Hub is proposed
to: (1) coordinate and integrate the efforts of all the funded projects, (2) build an efficient consortium infrastructure
to serve as a center for the collaborative efforts, and (3) provide the 4DN web portal as a central resource
gateway to access all the 4DN-Network generated tools, policies, guidelines, protocols, reagents, cell lines, and
as a central hub for the outreach activities. Our major deliverables are: (1) an organizational structure composed
of a steering committee and problem-solving working groups with a clear report chain to enable effective
communications and decision-making processes, establish co-organizers and schedule, clarify action items, and
ensure execution of the action items; (2) 4DN Web Portal (https://www.4dnucleome.org/), which is the always
up-to-date community-wide resource and point of access for all data, protocols, reagents, resources, and
methods; (3) 4DN internal wiki, the central organized resource for all teams, centers, and working groups to
document internal progresses. (4) 4DN annual meetings, including the "kick-off" meeting in winter 2020 and the
subsequent annual meetings and 4DN-ASCB (American Society of Cell Biology) satellite meetings; (5) 4DN
outreach workshops at Keystone symposia and American Society of Human Genetics (ASHG) meetings, and
on 4DN YouTube channel.

Public health relevance
The second phase of NIH Common Fund 4D Nucleome Network Organizational Hub Narrative The second phase of the 4DN program will study chromatin dynamics in live cells, complex tissues, and disease conditions. The 4DN Organizational Hub is proposed to: (1) coordinate and integrate the efforts of all the funded projects, (2) build an efficient consortium infrastructure to serve as a center for the collaborative efforts, and (3) provide the 4DN web portal as a central resource gateway to access all the 4DN-Network generated tools, policies, guidelines, protocols, reagents, and cell lines.